A Biomedical Mass Spectrometry Resource: Ongoing Driving Biomedical Projects

Project Summary
The Washington University NIGMS Biomedical Resource seeks to continue its successful collaborative work
with biomedical researchers engaged in understanding disease and maintaining human health. This Resource
supports a wide array of scientists requiring structural proteomics and complex lipidomics by expertly using
mass spectrometry tools, many of which were developed at this Resource over the last 15 years. The
dedicated scientists at the Resource have more than a century of combined experience and continue to
collaborate with investigators working on important biomedical problems including viral pathogens like Ebola,
Dengue, Zika, and Marburg, bacterial pathogens such as the causative agents of tuberculosis and leishmania,
plasmodia that cause malaria, Alzheimer's and Parkinson's diseases, diabetes, metabolic syndrome, urinary
tract infections, and cancer. Resource staff investigators, motivated by national and international collaborators
in academic, industrial, and governmental laboratories, provide support for the study of cellular calcium
regulation, lipid metabolism, antibody-antigen binding, and many other problems in structural and functional
biology. In addition, the dedicated scientists at this Resource will support successful dissemination, training,
and outreach to the scientific and broader communities. This grant will allow them to continue the application of
mass spectrometry to these problems as they transition to other sources of support that allow them to honor
commitments to their large and diverse group of collaborators.

Public health relevance
Project Narrative The Washington University NIGMS Biomedical Resource provides support for research scientists and clinicians who pursue the maintenance of human health and the treatment of human disease. The Resource provides mass spectrometry expertise and service to a national and international group of collaborators who study viral diseases like Ebola and Dengue Fever, bacterial pathogens implicated in Leishmania and tuberculosis, cancer, Alzheimer's disease, Parkinson's disease, and diabetes.